Computer-facilitated Screening and Brief Intervention in pediatric primary care to reduce underage drinking: a large multi-site randomized trial (ADMIN SUPP: Special Interest)

PROJECT SUMMARY/ABSTRACT
This is an administrative supplement in support of the parent grant (5R01AA027253), which allows
modifications to be made to the study materials and procedures to address considerations for minoritized
adolescent health disparities and the influences of social determinants of health on our study aims. The goal of
the parent grant is to test the effectiveness of a promising computer-facilitated adolescent Screening and Brief
Intervention (cSBI) system for delivery by pediatric primary care clinicians in a cluster-randomized controlled
trial of patients ages 14-17 years with an upcoming annual well-visit who report unhealthy alcohol use or
having ridden with an impaired driver in the past 12 months. Up to 40 pediatric primary clinicians across up to
10 practices are being recruited and randomized into either a Usual care or cSBI arm, and we expect at least
1,300 of their eligible patients will be enrolled. The parent study primary aims are to test the effect of cSBI on
adolescents’ risk of heavy episodic drinking and on riding with an impaired driver/driving while impaired in the
past 12 months. This trial is being conducted in the American Academy of Pediatrics’ Pediatric Research in
Office Settings (PROS) national practice-based research network. This study is one of the largest pediatric
trials to date of substance use screening and brief intervention in primary care settings. In this supplement, we
seek to enhance understanding of disparities in substance use-related risk among adolescents who are sexual
and gender minority (SGM). SGM adolescents are at greater risk of unhealthy substance use behaviors and
substance use disorders compared to their non-SGM peers. Nonetheless, SGM adolescents have been
underrepresented in primary care-based screening and brief intervention research studies aimed at early
detection and prevention of substance use. Collaborating with researchers who have SGM expertise and with
a community advisory board, we will develop recruitment materials that appeal to SGM adolescents in general
pediatric clinic settings, as well as clinician guidance on SGM-friendly language and environment to enhance
inclusion of SGM adolescents in the trial. We will add measures of sexual orientation and transgender status to
more accurately identify SGM adolescents, and several measures accounting for social determinants of health
that influence substance use risk (e.g., bullying, social support, school environment). The goal of adding these
measures is to shed light on the role of SGM status and SGM-relevant social determinants of health exposure
on substance use risk among adolescents in our study.

Public health relevance
PROJECT NARRATIVE This project seeks to enhance understanding of disparities in substance use-related risk among adolescents who are sexual and gender minority (SGM) as an administrative supplement to a large multi-site randomized controlled trial of a promising computer-facilitated Screening and Brief Intervention (cSBI) system designed for delivery by pediatric primary care clinicians. The cSBI system is aimed at reducing unhealthy alcohol use and related riding/driving safety risk among adolescents and will be tested in pediatric primary care practices of the American Academy of Pediatrics’ (AAP) Pediatric Research in Office Settings (PROS) national research network. We propose 1) to improve the representation of SGM adolescents in the study through SGM-inclusive recruitment materials and clinician guidance, and 2) to add measures of sexual orientation, transgender status, and social determinants of health (SDoH) that often underlie health disparities, to permit exploration of intervention outcomes by SGM status and by SDoH.